GENETIC MAPPING STUDIES IN INFLAMMATORY BOWEL DISEASE

The inflammatory bowel diseases are complex genetic disorders. Whole genome scanning to identify chromosomal regions containing disease loci will be performed. Affected pedigree member pairs will be genotyped by polymerase chain reaction amplification of microsatellite markers using fluorescent labeled primers.